HD2A RASC-Research and Evaluation Core

RESEARCH AND EVALUATION CORE: PROJECT SUMMARY/ABSTRACT
Although effective primary prevention, harm reduction, treatment, and recovery support interventions for
substance use disorders and pain exist, they are not widely available. Crosscutting dissemination and
implementation (D&I) scientific methods are required to select and deliver effective and efficient
implementation strategies under variable contexts. The Research Adoption Support Center’s Research and
Evaluation (R&E) Core, in concert with the Administrative, Substance Use Disorder Implementation Support
(SUD-IS) and Pain Implementation Support (Pain-IS) cores, utilizes an integrated, multidisciplinary, iterative
approach to provide rapid assessment, expert technical assistance, and advance the long-term adoption and
sustainment of evidence-based interventions. The overarching goal of the R&E Core is to elevate the D&I
capability and translational long-term impact of the HD2A Innovation Projects. We achieve this via
standardized baseline information and on-demand support for data, analytic, and research translation needs,
all toward leveraging sustainable change through science-based financing and policies. We will provide state-
of-the art methodological support in D&I measurement, frameworks, modeling, and testing/evaluation, guided
by R&E Core experts who have conducted extensive work across the four HHS pillars. Aligned with other
RASC cores, we are guided by 3 dynamic phases: 1) ASSESS Innovation Projects’ baseline D&I capacity via 3
methods; 2) ASSIST the Innovation Projects in increasing D&I capability, while supporting harmonized data
collection and reporting across projects; and, 3) ADVANCE Innovation Projects’ potential for sustainment and
scale-up, and serve as the D&I research methodology resource to the HD2A Modeling and Economic
Resource Center (MERC) and Data Infrastructure Support Center (DISC). A key function of the R&E core is
the formative evaluation, a phased evaluation that will incorporate lessons learned within and across HD2A
grantees, with formative evaluation reports (Years 1, 3) focused on providing insight to support timely decision-
making and course corrections by grantees and NIH, and a final report (Year 5) focused on informing future
initiatives of this kind. We also will conduct 5 Rapid Turnaround Research Projects designed to produce
knowledge to address persistent or emerging barriers to implementation or sustainment identified by HD2A
grantees. The Year 1 project will focus on the role of insurance coverage and other financing
and reimbursement barriers to the widespread adoption of medications for opioid use disorder (MOUD).
Within and beyond the HD2A program, we boldly seek to contribute knowledge and methods to the addiction
and pain intervention fields with the ultimate goal of transformational and equitable public health benefit.